Effects of DDE exposure on adipose tissue function, weight loss and metabolic improvement after bariatric surgery: A new paradigm for study of lipophilic chemicals

Abstract
The environmental obesogen hypothesis posits that lipophilic persistent organic pollutants (POPs) accumulate
in adipose tissue (AT) and can disrupt metabolic systems. However, the underlying molecular mechanisms of
these toxicants on AT function remain poorly understood. As the most studied POP, dichlorodiphenyl-
dichloroethylene (DDE), a persistent metabolite of the insecticide dichlorodiphenyl-trichloroethane (DDT),
provides a model for assessing the metabolic health impact of lipophilic POPs. Almost all U.S. children and
adolescents have detectable DDE blood levels. Despite abundant evidence from experimental studies showing
that DDE disrupts metabolic homeostasis, mechanisms underlying metabolic disruption by DDE in humans are
unclear. We therefore propose a novel study design for investigating mechanisms of DDE metabolic effects in
humans, based on a remarkable archive of clinical data and visceral AT samples from the Teen-Longitudinal
Assessment of Bariatric Surgery (Teen-LABS) study and an in vitro human adipocyte experimental model. We
hypothesize that the large metabolic changes after bariatric surgery provide a “natural experiment” that will
magnify effects of the prototypical obesogen DDE, and that DDE in visceral AT will attenuate the reduction in
body mass index and insulin resistance after bariatric surgery in a concentration-dependent manner (Aim 1).
Although we know that high doses of DDE impair thermogenesis and insulin signaling in animal models, we still
do not know whether these mechanisms underlie metabolic disruption by DDE in humans. We will assess effects
of DDE on these pathways in a human primary adipocyte cell line, an experimental model that will be free from
the potential for uncontrolled confounding in human observational studies and that may also identify new
pathways (Aim 2). We will then test these pathways in metabolome and transcriptome profiles of human AT
from Teen-LABS study participants, using a hierarchical modeling approach (Aim 3). Finally, we will integrate
results from the DDE omics analyses in human AT and in the adipocyte cell line, using a novel latent variable
modeling framework, to identify subgroups of adolescents who have less weight loss and less improvement in
insulin resistance after bariatric surgery, based on their DDE exposure and multi-omics profile in AT (Aim 4).
The proposed research will be the first human study to examine mechanisms of DDE toxicity to AT in humans,
using adipose tissue-specific exposure and omic measures, and clinically relevant metabolic outcomes such as
BMI and insulin resistance. A strong interdisciplinary team of investigators brings expertise in environmental
epidemiology, bariatric surgery, toxicology, omics, and biostatistics. Our study, integrating in vitro and human
observational approaches, has the potential to establish a new paradigm for the study of lipophilic obesogenic
chemicals and to advance our understanding of environmental contributions to obesity and type 2 diabetes.

Public health relevance
PROJECT NARRATIVE This study will test the hypothesis that higher levels of persistent chemicals like the DDT metabolite, DDE, that are concentrated in fat, are associated with reduced weight loss and reduced improvement in metabolic health after bariatric surgery. We seek to identify molecular pathways, altered by DDE in fat tissue, that underlie these effects. The goal is to develop a new paradigm for studying effects of persistent chemicals in fat that could ultimately lead to new strategies for treatment and prevention.